CORE--Pilot /Feasibility

The Pilot and/or Feasibility Core will have responsibility for evaluating and supporting new and ongoing pilot studies that will advance knowledge in the area of Self Management Interventions for Populations at Risk. This Core will be directed by two senior faculty at the School of Nursing, Drs. Ann Williams and Ruth McCorkle.